Quantitative Analysis of Labile Metabolites in Biological Samples

PROJECT SUMMARY
Coenzymes and antioxidants mediate hundreds of biochemical reactions and are fundamental to cellular and
mitochondrial function. The redox coenzymes undergo reversible oxidation and reduction reactions, while the
balance between oxidized and reduced forms drive important cellular functions including regulation of ion
channels, cell signaling, cell survival and death. Cellular dysfunction associated with these coenzymes has been
implicated in many diseases including cancer, heart failure, diabetes, obesity and aging. Given the importance
of NAD metabolites and their declining levels in aging, numerous clinical trials of nutritional supplementation of
the coenzymes' precursors are currently underway. Despite the immense interest and the need to determine
cellular and subcellular levels of these metabolites, no reliable method exists currently for their simultaneous and
comprehensive measurement. The major challenge is that these molecules are unstable and their levels are
sensitive to sample harvesting, extraction and measurement conditions. As a result, errors involved with their
measurement using conventional methods often outweigh biological variations and potentially lead to incorrect
inferences. To overcome these challenges, and building on our preliminary studies of methodological
developments using nuclear magnetic resonance (NMR) spectroscopy, in this proposal, we seek to develop
methods to reliably measure the coenzymes and antioxidants in blood, cells, tissue as well as two subcellular
components: mitochondria and cytoplasm. Further, we seek to develop methods to measure these coenzymes
in live cells and mitochondria in real time. We will also translate the protocols and measurements to the widely
used mass spectrometry platform for broader dissemination. The proposed project has three main aims: (1)
Develop methods to reliably measure the coenzymes and antioxidants in blood, tissue, cells and two subcellular
components: mitochondria and cytoplasm using NMR spectroscopy; (2) Develop methods to measure the
coenzymes and antioxidants in live cells and mitochondria in real time using NMR spectroscopy; and (3) use
NMR spectroscopy to guide the translation of the methods for analysis of the unstable (coenzymes and
antioxidants) as well stable metabolites to mass spectrometry for wider applications in the metabolomics field.
The outcome will provide robust methods to analyze important coenzymes and antioxidants in a broad range of
biological sample types that can be used by many researchers. The new methods will also provide novel avenues
for investigation of live cells and mitochondrial metabolism in real time. These developments will impact
numerous areas of biomedical science.

Public health relevance
PROJECT NARRATIVE This study proposes to develop robust methods for analysis in one step of coenzymes and antioxidants that are fundamental to the functioning of all living cells and their abnormal levels are associated with numerous diseases including cancer, heart failure, diabetes, and obesity. Owing to the extremely unstable nature of these molecules, conventional analysis methods are suboptimal and lead to inaccurate and misleading outcomes in the assessment of cellular functions. Our ability to reliably measure the unstable metabolites in one step based on the outcome of the current investigations impacts numerous areas of biomedical science.